Mechanisms of Macrophage-Mediated Immune Evasion in Residual Tumors

Abstract
Oncogene targeted therapies offer a safe and effective approach to suppress cancer since these drugs spare
healthy tissues by selectively targeting driver mutations in cancer cells. Despite a strong initial response to these
therapies, however, patients eventually progress and relapse within months of treatment due to the survival of
residual tumor cells. These residual disease cells are crucial to eradicate since these cells often serve as the
reservoir for resistance and relapse. However, the biological and immunological properties of residual tumor
cells are poorly understood. We studied the immunological properties of residual cancer cells and the molecular
mechanisms governing it. Using a BRAF mutant mouse melanoma model, we found that residual cancer cells
that survive in vitro BRAF therapy exhibit immune evasion in vivo. Our preliminary data suggest residual tumor
cells evade the immune system by targeting macrophages of the immune system through upregulation of “don’t
eat me” markers such as CD47 (cluster of differentiation 47). Our findings are reproducible in human BRAF, ALK
and KRAS mutant cancer cell lines that all show CD47 upregulation upon treatment of respective targeted
therapies. Importantly, CD47 blockade has been shown to have an antitumor effect in many mouse tumor models
and is currently under investigation in clinical trials to determine its efficacy in human patients. Thus, our
preliminary data linking oncogene targeted therapies to CD47 upregulation has significant implications for
combining these therapies in clinical practice. To further investigate our findings, we propose a series of
integrative transcriptomics and functional genomics approaches to uncover potential mechanisms to target and
engineer the immune-mediated clearance of residual tumor cells.

Public health relevance
Project Narrative Residual tumor cells that survive oncogene targeted therapies pose a challenge to achieving durable responses since these cells often serve as the reservoir for tumor relapse and progression. We recently found that residual cells evade immune recognition by targeting macrophages of the immune system. In this proposal, we propose a series of mechanism-based approaches to uncover potential targets to engineer the immune-mediated clearance of residual tumor cells.